San Diego Alzheimer's Disease Resource Center for Minority Aging Research (San Diego AD-RCMAR)

ABSTRACT
The San Diego Alzheimer’s Disease-related Resource Center for Minority Aging Research (San Diego
AD-RCMAR) [formerly San Diego Resource Center (SDRC) for advancing Alzheimer’s Research in Minority
Seniors (ARMS)] is a collaboration between the University of California San Diego (UCSD) and San Diego
State University (SDSU) that will leverage the strength of both institutions to identify, train, and support
scientists from diverse backgrounds committed to behavioral and social science research on Alzheimer’s
Disease and Related Dementias (ADRD). The SD AD-RCMAR will address ADRD inequities through novel
research targeting multilevel factors to inform interventions focused on Hispanic/Latino, limited English
proficient (LEP) and refugee communities. We will use the NIA Health Disparities Research Framework to
guide our investigation of emerging and established risk factors at environmental, sociocultural, behavioral and
biological levels across the life course and focused on priority populations in the San Diego region. We will
train, mentor and support our Scientists to use novel research designs, measurements and analyses and to
integrate diversity, equity, inclusion and accessibility (DEIA) concepts into their work. Informed by and in
partnership with the Hispanic/Latino (hereafter referred to as Latino), LEP and refugee communities and
organizations representing them, we will work to meet their needs and increase their representation in
research to decrease inequities in healthy cognitive aging. The SD AD-RCMAR will be led by three Principal
Investigators (MPIs): Drs. Alison Moore (UCSD-Geriatrics, Gerontology and Palliative Care), Paul Gilbert
(SDSU-Psychology) and John Elder (SDSU/UCSD-Public Health). The center includes four cores: Leadership
and Administrative (LAC), Research Education (REC), Analysis (AnC) and a new Community Liaison and
Recruitment Core (CLRC) and will be composed of diverse leaders and investigators. The LAC will provide
administrative and intellectual leadership to the San Diego AD-RCMAR to plan, manage and coordinate its
activities, and maintain its scientific focus. The REC will nurture AD-RCMAR Scientists via DEIA-grounded
mentorship, education, career development activities and resources to attain independent research careers
and leadership skills. The AnC will provide training in advanced quantitative and qualitative analytic
techniques for the collection, management, and analysis of data, facilitate access to existing sources of data
for ADRD research, and support scientists to disseminate their research findings. The CLRC will train
Scientists on community engagement research methods, build and strengthen community collaborations, and
promote recruitment and retention of minoritized populations. The SD AD-RCMAR will enhance and increase
the diversity of our nation’s scientific workforce with outstanding AD-RCMAR Scientists committed to careers in
ADRD research focused on understanding and addressing multilevel risk factors to reduce ADRD disparities.

Public health relevance
Relevance to Public Health The identification, recruitment, selection, and mentorship of scientists from diverse backgrounds to conduct research on Alzheimer’s Disease and Related Dementias (ADRD) (i.e., AD-RCMAR Scientists) and to launch their independent research careers will enhance the diversity of the aging research workforce. The work of the AD-RCMR Scientists and the San Diego Alzheimer’s Disease Resource Center for Minority Aging Research will promote critical advances in our understanding and ability to target multilevel factors and interventions to address ADRD inequities among Hispanics/Latinos, limited English proficient (LEP) and refugee communities.